PROJECT 3: Remote control of hematopoiesis in CVD

Atherosclerosis, the underlying cause of myocardial infarction and stroke, is a lipid-driven
chronic inflammatory disease characterized by lipoprotein and leukocyte accumulation in the
vessel wall. With some exceptions, all leukocytes are produced in the bone marrow. Here, we
will explore long-distance communication between disease locations and hematopoiesis in the
bone marrow with particular emphasis on the brain as the organ connecting cardiovascular
tissue with the bone marrow. In two aims, we will first elucidate the role of specific brain regions
in modulating myelopoiesis and atherosclerosis and then elucidate he role of specific brain
regions in modulating myelopoiesis in myocardial infarction. We will build on strong published
and unpublished preliminary data showing that atherosclerosis and MI influence myelopoiesis in
the bone marrow, that specific regions in the brain control peripheral immune cell numbers and
function and that manipulating stress centers in the brain influences bone marrow function. We
will work with investigators from the other projects of the PPG, as well as with the Cores. We will
employ many of our established gain and loss-of-function interventions, including
chemogenetics, optogenetics, viral tracing, brain-region specific knockout mice, and cell-type
specific stress hormone receptor knockout mice to investigate how different brain regions
contribute to hematopoiesis in atherosclerosis and myocardial infarction. These will be
combined with classical tools of immunology and vascular biology that we have used routinely
over many years. Collectively, these experiments will identify new lines of long-distance
communication between diseased sites (lesion, infarct), elucidate the underlying mechanisms,
and pave the way for new therapeutic approaches for cardiovascular disease.